SCH: Al-driven Flexible Electronics for Cardiac Organoid Maturation

The ability to control and monitor the maturation of human-induced pluripotent stem cell (hiPSC)-derived
tissues is critical for tissue engineering, regenerative medicine, pharmacology, and synthetic biology. This
proposal presents an artificial intelligence (Al)-driven "cyborg tissue" platform that integrates tissue-like
flexible electronic sensors and actuators with developing tissues and provides multimodal recording and
control. Machine learning-based mathematical models will be built to integrate the data and tissue
maturation status readout through the in situ single-cell RNA sequencing. This closed-loop system will
control the tissue-wide distributed electrical actuations to promote tissue development. The aim is to use
hiPSC-derived cardiac organoids as a model system to demonstrate that this Al-driven cyborg tissue
platform can improve the maturation and eliminate the variations in patient-specific hiPSC-derived tissue
samples.
Specifically, flexible and stretchable mesh nanoelectronics with miniaturized multifunctional sensors and
electrical stimulators will be fully implanted, integrated, and distributed across the entire three-dimensional
(3D) volume of organoids for continuous, multiplexed sensing and actuation. Additionally, in situ
electro-sequencing will be used to combine spatially resolved single-cell molecular phenotypes with the
functional readouts from the electronics. A statistical learning architecture will be developed for modeling,
testing, and interpreting multimodal electrical activities, mechanical contractile, gene regulatory, and
signaling networks to determine the functional maturation of the organoids. Finally, a feedback control
system will be implemented for real-time experimental design enhancement, electrical stimulation
optimization, and model refinement to improve the functional maturation of cardiac organoids.
The success of this work will potentially provide an improved mechanistic understanding of how genetic,
molecular, electrical, and mechanical processes regulate the maturation of the hiPSC-derived cardiac
organoids and establish an Al-controlled bioelectronics system to sense and control the functional
maturation of hiPSC-derived cardiac organoids for various regenerative medicine and pharmacological applications. The technology is likely to be generalizable to help scientists understand the maturation and
functions of virtually any kind of developing tissue and organoid systems and even in vivo systems. This
proposed research will combine AI, machine learning, computational biology, biomedical informatics and
multimodal cell data to advance stem cell maturation and enable new data-driven discovery, which aligns with
the mission of the National Library of Medicine.

Public health relevance
This proposal seeks to establish an Al-driven "cyborg tissue" platform that integrates flexible electronic sensors and actuators with developing human-induced pluripotent stem cell (hiPSC)-derived cardiac tissues for monitoring and controlling tissue maturation. The closed-loop system will collect multimodal electrical, mechanical, and genetic data from cells, analyze the data using statistical models, and generate control policies through reinforcement learning to promote tissue maturation via distributed electrical actuations. By improving our understanding of how genetic, molecular, electrical, and mechanical processes regulate hiPSC-derived cardiac organoid maturation, this resulting bioelectronics system will have wide-ranging applications in regenerative medicine and pharmacology.